Novel Calcium Signaling Nanodomains in Vascular Smooth Muscle Cells

Smooth muscle Ca2+ signaling mechanisms are crucial regulators of arterial contraction and blood
pressure. Abnormalities in arterial smooth muscle cell (SMC) Ca2+ signaling mechanisms have
been linked to vasoconstriction, vascular remodeling, and blood pressure elevation in
hypertension. Therefore, identifying a new Ca2+ signaling mechanism could provide fresh impetus
for designing novel therapeutic targets that lower blood pressure in hypertension. In this regard,
TRPV4 (transient receptor potential vanilloid 4) ion channels are a well-known Ca2+-influx pathway
in SMCs. Using smooth muscle-specific TRPV4-knockout mice, we provided first evidence that
SMC TRPV4 channels increase resting blood pressure and contribute to blood pressure elevation
in hypertension. Moreover, our preliminary data demonstrate two TRPV4 channel-containing
signaling nanodomains in SMCs with opposite functional effects: (1) constrictor nanodomains
involving nerve stimulation-induced activation of α1 adrenergic receptors (α1ARs)–protein kinase
C (PKC)-anchoring protein AKAP150–TRPV4 channel signaling; and (2) dilator nanodomains
activated by intraluminal pressure and comprising caveolin-1 scaffolded Piezo1–TRPV4–Ca2+-
activated K+ (BK) channel signaling. Further, we show that constrictor α1AR–TRPV4 channel
signaling is accentuated in arteries from a mouse model of hypertension and hypertensive
patients, whereas dilator TRPV4–BK channel signaling is reduced. We hypothesize that
miscommunication between the signaling elements disrupts the balance between constrictor and
dilator signaling nanodomains and leads to blood pressure elevation in hypertension. In Aim 1,
we will use smooth muscle-specific knockout mice, protein co-localization, patch-clamp
electrophysiology, and blood pressure radiotelemetry to determine the molecular mechanisms
underlying the excessive activation of constrictor α1AR:AKAP150:PKC:TRPV4 nanodomains in
hypertension. In Aim 2, we will determine the molecular mechanisms responsible for the reduced
activity of dilator Piezo1:TRPV4:BK channel nanodomains scaffolded by caveolin-1 in
hypertension. The clinical relevance of studies in each Aim will be established by experiments in
arteries from non-hypertensive and hypertensive individuals. Collectively, the proposed studies
will establish novel SMC Ca2+-signaling nanodomains that control blood pressure and identify
specific impairments at these nanodomains in hypertension.

Public health relevance
Nearly half of adults in the United States have hypertension. Abnormalities in vascular smooth muscle cell Ca2+ signaling mechanisms have been linked to increased arterial contraction and elevated blood pressure in hypertension. We have identified two new Ca2+-signaling pathways in vascular smooth muscle cells that exert opposing effects in the control of blood pressure. The proposed studies will investigate the individual components of these pathways under normal conditions and in hypertension. These studies will advance our understanding of blood pressure regulation by vascular smooth muscle cells and identify novel therapeutic targets for treating elevated blood pressure in hypertension.